Planning and Evaluation

The overall objective of Cancer Center Planning and Evaluation is to provide effective and integrated processes to ensure that the Cancer Center fulfills its mission set by the NCI and the University of Alabama at Birmingham. These planning activities involve all of our Senior Leaders, Program Leaders, and on occasion, members of the Cancer Center. Major planning occurs in the Director's Council, made up of Senior Leadership, with significant advice in planning and evaluation from the External and Internal Advisory Committees. Evaluation consists of both external review by the External Advisory Committee, and two avenues of critical internal review. Internal review comes both from review of the entire CCC by an Internal Advisory Committee made up of leaders across the UAB campus, and evaluation of the shared facilities by an internal committee. Additional planning occurs in the bi-monthly Program Leaders meeting, the annual Program and Senior Leadership Retreat, and the biennial Cancer Center Strategic Planning Retreat. Some ofthe specific planning processes include the following. • Our External Advisory Committee (EAC) consists of ten members with extensive Cancer Center leadership and nationally recognized expertise required to critically evaluate and advise regarding the Cancer Center's programmatic and organizational development. The EAC meets annually. • The Center holds an annual center-wide research retreat in order to stimulate transdisciplinary research collaboration and program development as well as an annual priority and strategic planning retreat for identification of Cancer Center scientific priorities, recruitment needs, and for major program evaluation and development. This retreat includes leadership on an annual basis and the entire Cancer Center membership on a biennial basis. • The Cancer Center also sponsors community-based conferences to facilitate interactions with the community and providers who can be extremely important to our clinical and prevention trials. • The major planning and evaluation activity occurs in the monthly Director's Council composed of all Senior Leaders in the Cancer Center.

Public health relevance
A Comprehensive Cancer Center represents a major investment by the NCI, and, by extension, the taxpayers of the United States. Effective planning and evaluation are critical to assure that the goals of the NCI and ofthe Public Health Service are being met. Our Planning and Evaluation processes are designed to meet that need.